Maturation of human humoral immunity through repeat malaria challenges

Malaria continues to be among the world’s most virulent infectious diseases accounting for the death of ~0.4
million people a year. Unlike many viral infections, children usually have repeated clinical episodes, but by
adulthood, the majority of individuals living in endemic areas are protected against disease, not parasite
carriage. The reasons for this gradual response to the parasite are not well established. Eventually antibodies
are produced in adults that reduce parasitemia and fever when passively transferred to children with malaria,
indicating a role for antibody-mediated immunity. However, it has been difficult to study this slow development
of immunity to natural infection in the field, since there is no way to control for parasite strain or exposure
timing. Animal studies, while allowing controlled inoculations of specific parasite strains, are complicated to
apply to human infections due to differences across host and parasite species. To address these limitations,
we carried out a clinical trial to systematically evaluate the immune response of malaria-naïve volunteers to an
initial exposure to uninfected mosquitoes, followed 2 months later with Plasmodium falciparum (Pf)-infected
mosquito bites and then 2-3 subsequent challenges each with the mosquitoes infected with the same strain of
Pf. The use of the controlled human malaria infection (CHMI) model allowed control of the timing of parasite
exposure and therefore the early response to sequential infections could be directly monitored. As observed
with children in malaria endemic countries, the initially naïve volunteers continued to be susceptible through
the multiple infectious challenges, but the time to a positive blood smear, termed patency, increased
significantly overtime. Symptoms decreased significantly by the 3rd and 4th challenges indicating the beginning
of clinical immunity and preliminary data indicates plasma from the two subjects with the longest patency delay
reduced liver cell invasion consistent with the development of pre-erythrocytic immunity. This unique, well-
controlled infection model allows us to carefully follow the production of antibody-secreting plasma cells and
parasite-specific memory B cells from before parasite exposure through 3 to 4 challenges with mosquitoes
infected with the same strain of P. falciparum. Our preliminary analysis of the antibody repertoire of circulating
plasma cells demonstrates marked clonal expansion followed by population collapse and the appearance of
distinct clones. We hypothesize that B cells stimulated by the parasite proliferate and differentiate preferentially
into plasma cells, not memory cells. Such a model could explain the lack of a sustained memory response to
infection and subsequent delay in the acquisition of immunity. The specific aims are 1) Characterize parasite-
specific memory B cell production through repeat challenges. 2) Evaluate parasite-specific memory B cells
isolated after each CHMI to parasite stimulation in vitro. 3) Assess the Pf liver and blood stage growth inhibition
through repeated CHMI. Together the results will advance our understanding of the memory response to
Plasmodium, which is critical for the development of protective immunity.

Public health relevance
PROJECT NARRATIVE Despite over a half a century of effort, no effective vaccines have been developed against malaria, which still causes in over 450,000 deaths a year, primarily in children. The proposed study examines the development and maturation of the humoral immune responses following sequential parasite exposures. The findings will be used to design understand the development of immunity to facilitate the design of more effective vaccines.